Unraveling Bacterial Cell Wall Biosynthesis and Sensing via Synthetic Analogs

PROJECT SUMMARY
Over two million people are afflicted with bacterial infections resistant to FDA-approved antibiotics in the United
States every year. Of those, more than 20,000 of these patients die as a result of these infections. The surge in
drug-resistant bacteria has become a growing pandemic and threatens to undermine medical gains made in the
last several decades. It has proven difficult to discover new antibiotics for a myriad of reasons, including under
developed concepts related to bacterial targets. To improve our ability to design and discover novel tools to
combat bacterial infections, it becomes important to better understand their biology. Bacterial cell walls are
unmatched targets for antibiotics, including being the target of many of clinically relevant agents. Yet,
foundational aspects of bacterial cell wall assembly and its interaction with the host organisms remain vastly
under explored. Our laboratory has extensive experience in designing cell wall analogs that become metabolic
processed by bacterial cells during cell wall growth and division. Within these substrate analogs, we introduce
non-native tags (e.g., click chemistry handles, biotin, fluorophores) that can be leveraged to elucidate the
processes underpinning cell wall biology.
For this proposal, we will apply these strategies towards two main areas: the development of probes related to
the processing of peptidoglycan, a primary component of bacterial cell wall and to the development of assays
that report on the accessibility of components on the cell surface of Gram-positive bacteria. Peptidoglycan is a
single large biomacromolecule composed of unique building blocks, including a short peptidic fragment called
stem peptide. Our laboratory has extensive experience in labeling cell wall of live bacteria to install unnatural
epitopes. The metabolic and site-selective labeling will be the basis for elucidating sites of peptidoglycan
modifications and will be the anchor point for the accessibility assay. Through these investigations, we project
that we will add insight into cell wall biosynthesis that can empower drug discovery and development.

Public health relevance
PROJECT NARRATIVE This project addresses two key areas of primary importance in our understanding of bacteria physiology: cell wall biogenesis and bacterial cell surface accessibility in Gram-positive bacteria. We have developed a novel approach aimed at capturing and unveiling these key bacterial cell surface features using unnatural building blocks that mimic cell wall components.